Using mitochondrial Ca2+ uptake as a therapeutic target for ALS

Amyotrophic lateral sclerosis (ALS) is a fatal, adult-onset neurodegenerative disease characterized by progressive motor neuron (MN) loss, muscle denervation, and eventually, paralysis. Currently, no effective treatments are available to stop or reverse ALS disease progression and the precise molecular mechanisms underlie ALS pathogenesis remain elusive. Prior studies revealed decreased mitochondrial respiratory chain activity, altered mitochondrial ultrastructure, and mitochondrial dysfunction in both MN and skeletal muscle (SM) in ALS patients and mouse models. The first sign of ALS pathology occurs at the neuromuscular junction (NMJ), where presynaptic MN axons connect with postsynaptic SM end plates. To date, whether signals resulting in the initial NMJ damage are from MN or SM remain unclear. In this project, we aim to determine the tissue-specific causative role of mitochondrial Ca2+ uptake in SM and MN in disease onset and progression, and the therapeutic efficacy of reducing mitochondrial Ca2+ uptake on NMJ and SM function in ALS mice. We hypothesize that mitochondrial Ca2+ mishandling in both SM and MN actively contribute to ALS disease pathogenesis and that attenuating mitochondrial Ca2+ uptake mitigates mitochondrial damage and preserves NMJ/muscle function. To test this hypothesis, we will use transgenic mice with inducible, SM or MN-specific expression of a dominant negative form of the mitochondrial Ca2+ uniporter to specifically and selectively reduce mitochondrial Ca2+ uptake in SM and MN in hSOD1G93A mice and C9-500 (C9orf72) mice, two mouse models associated with the most prevalent genetic causes for ALS. The central hypothesis will be tested in two Specific Aims. Aim 1 will determine the role of mitochondrial Ca2+ uptake in SM or MN in survival, motor function, NMJ function and in vivo muscle performance in hSOD1G93A and C9-500 mice. Aim 2 will assess the impact of tissue-specific inhibition of mitochondrial Ca2+ uptake in SM or MN on NMJ and muscle structure, MN survival, muscle intrinsic contractile properties, mitochondrial structure and mitochondrial bioenergetics in SM of hSOD1G93A and C9-500 mice. This project will: 1) provide a systematic, longitudinal characterization of SM and NMJ function from a cellular level to whole animal level at different stages of disease progression in hSOD1G93A and C9-500 mice; 2) determine the degrees to which defects in mitochondrial Ca2+ uptake in SM or MN contribute to altered NMJ structure/function, disease onset and progression in hSOD1G93A and C9-500 mice; 3) provide the first detailed dissection on the relative role of mitochondrial Ca2+ uptake in SM and MN in ALS phenotype using the same genetic models and determine the origin of the signals that result in NMJ destruction (from SM or MN or both); 4) provide mechanistic evidence for whether mitochondrial Ca2+ mishandling is a trigger or a target for disease progression in ALS mice, regardless of the causing mutations (mitochondrial related or non-mitochondrial related); and most importantly, 5) test the validity of a potential new therapeutic target (mitochondrial Ca2+ uptake, or the mitochondrial Ca2+ uniporter, MCU) for the treatment of ALS.

Public health relevance
The global objective of this proposal is to investigate the tissue-specific causative role of aberrant mitochondrial Ca2+ uptake in skeletal muscle and motor neuron in Amyotrophic Lateral Sclerosis (ALS) pathogenesis. Specifically, we will determine the impact of aberrant mitochondrial Ca2+ uptake in skeletal muscle and/or motor neuron on the survival, motor neuron loss, exercise performance, muscle force generation, neuromuscular junction structure/function, and intracellular Ca2+ release properties and mitochondrial function in skeletal muscle fibers, at different stage of disease progression in two established mouse models of ALS. Results from this project will provide pre-clinical evidence needed to determine if excessive mitochondrial Ca2+ uptake in skeletal muscle and motor neuron is a viable therapeutic target for ALS treatment.